Decoding the mechanism of inflammatory memory in human epithelia

Project Summary
Remitting-relapsing inflammatory disorders affect millions of people and have no cure. Psoriasis (PsO) is a
prototypic remitting-relapsing inflammatory disease that despite treatment success in promoting symptom
remission, patient relapse almost always occurs. Psoriatic lesions often recur in the same location, indicative of
locally encoded disease memory. Our lab and others have uncovered that epithelial stem and progenitor cells
(ESPCs) can remember inflammation by epigenetic mechanisms in murine models of disease. These long-lived
cells maintain chromatin accessibility to stress response genes long after inflammatory resolution. My preliminary
data suggest that keratinocyte stem cells in skin from resolved psoriatic lesions have an enrichment of
inflammatory transcription factors’ binding motifs in their differentially accessible regions. Additionally, my
preliminary data indicate that keratinocytes capable of encoding inflammatory memory and becoming sensitized
to secondary challenge have decreased binding activity of homeostatic transcription factors. The possibly
contrasting roles of inflammatory and homeostatic transcription factors in encoding inflammatory memory of
human epithelial cells is not understood. In this proposal, I will test the hypothesis that levels of homeostatic vs.
inflammatory TFs dynamically control epithelial memory formation following inflammation. My proposed studies
will utilize a human keratinocyte culture system and cutting-edge expression system to modulate levels of
homeostatic and inflammatory transcription factors and test their role in encoding and retaining cellular memory.
Altogether, these studies will decode the mechanistic effect that transcription factors have on inflammatory
memory encoding in human epithelial cells, potentially uncovering a critical disease mechanism in remitting
relapsing inflammatory disorders. Understanding the cellular and molecular basis of PsO disease memory in
ESPCs, as I propose here, could pave the way for developing curative therapies that limit relapse.

Public health relevance
Project Narrative Remitting-relapsing inflammatory disorders affect millions of people and have no cure despite periods of treatment success. Inflammation lastingly alters long-lived epithelial cells in psoriasis and may predispose them to relapse and epidermal pathology. We propose to decode the mechanism that underlies this inflammatory memory in human epithelial cells.